Targeting Tfh differentiation to increase the magnitude and durability of antibody responses in infant rhesus macaques after SHIV infection

PROJECT SUMMARY
Approximately 120,000 young children are newly infected with HIV-1 each year. In the absence of antiretroviral
therapy (ART), infants have a mortality rate of up to 50% within the first 2 years of life, but administration of ART
reduces morbidity and mortality and is now implemented early in life for most children. Unfortunately, even with
ART, children under 5 years old are at higher risk of mortality than older children or adults on ART. While a
number of factors may contribute to this increased mortality, a hyporesponsive immune system likely plays an
important role. Children living with HIV-1 have been shown to have diminished antibody responses, with a lack
of HIV-1 seroconversion after early ART and poorer antibody responses than their uninfected peers to common
childhood vaccinations. The overarching goal of our research is to improve HIV- and vaccine-specific antibody
development in children living with HIV-1 by targeting the differentiation of T follicular helper (Tfh) cells, which
provide critical survival and differentiation signals to B cells. Tfh differentiation is limited in infants compared to
adults, and our preliminary analysis of pediatric clinical samples identified elevated Helios expression in infant
CD4+ T cells as a potential regulator of Tfh cell development. CRISPR knock out of Helios in naïve CD4+ T cells
from cord blood or healthy adult blood before in vitro Tfh differentiation revealed a negative correlation between
the frequency of Helios+ cells remaining and subsequent Tfh cell differentiation. We hypothesize that
administration of a Helios degrader, DKY709, to target Helios expression in CD4+ T cells will improve Tfh cell
differentiation and subsequent antibody development after vaccination or infection. Due to the uniquely high
expression of Helios in infant CD4+ T cells but not adults, we will use the infant rhesus macaques model of HIV
to determine if Helios degradation by DKY709 will improve the magnitude and durability of antibody responses
to 1) vaccines administered to SHIVSF162P3 infected or naïve animals and 2) SHIVSF162P3 after early ART
administration. Together these studies will provide important preliminary data about the capacity of Helios
degradation to improve Tfh differentiation and humoral immune responses in infants, particularly in the context
of SHIV infection. Importantly, the results from either aim will provide critical information that can be used as the
basis for future research proposals. The candidate is currently a Research Assistant Professor in the Vaccine
and Gene Therapy Institute, which is located on the Oregon Health & Science University West Campus with the
Oregon National Primate Research Center. This provides a highly collaborative environment in which to do HIV
research with nonhuman primate models. Building on her previous research studying immune responses in
clinical cohorts, this proposal will further her training in using the infant SHIV infection model to assess immune
responses to therapeutic interventions and in developing clinical trials to translate research findings into infants.
Completion of the career development plan and innovative research study will provide a strong foundation upon
which to build a successful independent research career in pediatric HIV-1 immunology.

Public health relevance
PROJECT NARRATIVE Children living with HIV-1 can have low levels of HIV-specific antibodies and poorer antibody responses to vaccines than their peers, leaving them susceptible to additional infectious diseases. Here, we will use a proven animal model of perinatal HIV infection to study the dynamics of virus-specific and vaccine-specific antibody responses after using a novel strategy to target CD4+ T follicular helper cell differentiation in infants. If successful, these studies will offer insight into the development of antibody responses in children living with HIV-1 and provide an innovative approach to increase these responses to improve health.